Characterization of HIV Reservoirs in the Brain

We have just started sample collection and preparation for this project:
1) We have collected autopsy brain and peripheral lymphoid tissue from 4 patients with HIV.
2) We have synthesized digital droplet PCR primers for the detection of HIV reservoir in tissue.
3) We cultured 4 different cell lines for the extraction of genomic DNA and verification of integrated HIV genome with our synthesized primers. In addition, this genomic DNA will be used as positive control for our long read sequencing of HIV reservoir from HIV patient tissue.
4) We designed hybridization capture probe panel for the enrichment of HIV genomic fragment from the total genomic DNA extraction.
5) The equipment for this project is in the process of being purchased.